VCRC Administration Unit

The BVMC Administrative Unit (AU) is a central resource for addressing a wide range of administrative issues related to the conduct of proposed research, including human research regulatory issues, publications, reports, and fiscal management. The AU will also provide administrative support to all Projects and Cores, and will provide assistance in progress report generation, manuscript preparation, and central scheduling of research meetings and seminars. The AU is essential for the coordination of the interdisciplinary clinical programs that are part of the BVMC. The overarching goal will be to provide a mutually supportive environment to foster clinical research activities in the component projects through its various committees, meetings and interactions regarding research design and data analysis. Aim 1: Coordinate meetings and provide supportive environment for mutual exchange of ideas. The AU is available to the Leaders and Co-Leaders of all Cores and Projects for scheduling and coordinating committee meetings and research seminars. This includes scheduling and arranging travel and hotel accommodations for BVMC members to attend the annual in-person meeting in conjunction with PSO-sponsored scientific meetings. Aim 2: Provide administrative support to BVMC Projects/Cores. The AU will provide assistance in preparation of manuscripts and presentations, progress report generation, keeping track of current IRB approvals, and assisting Project/Core Leaders with fiscal management reports. The AU will also be responsible for updating the BVMC web server with relevant announcements, seminars, and a portal to research results. The AU will also be responsible for relaying all communications to/from the DMCC, NIH, and the larger RDCRC network.

Public health relevance
The Administrative Unit is essential for coordinating the interdisciplinary clinical research programs in the BVMC and for facilitating the communication between Project Leaders and Cores and between the BVMC and larger RDCRC network. The AU is a central resource for addressing a wide range of administrative issues related to the conduct of research, including meetings, publications, reports, and fiscal management.